Auto-Titrating Oral Appliance for Sleep Disordered Breathing

Project Summary/Abstract
Rush River Research Corp. (RRR) proposes to develop an auto-titrating oral appliance that fits
fully-in-the-mouth for Sleep Disordered Breathing (SDB) therapy. SDB, resulting from airway obstruction, is
directly linked to the four most costly diseases in the United States: heart disease, diabetes, obesity, and
cancer. Research has shown that SBD sufferers are three times more likely to die prematurely. Current
therapeutic devices, such as CPAP, surgery, and traditional non-auto-titrating oral appliances are the most
common therapy approaches to SBD, with CPAP being considered the gold standard. Despite 30 years of
CPAP commercialization, 90% of the potential U.S. and worldwide markets for SDB therapy remain untreated.
Lack of toleration of CPAP leads to poor compliance among users. Oral mandibular advancement appliances
typically provided, fit, and titrated by dentists are often an alternative for patients with unsuccessful
experiences with CPAP or with mild SDB. However, the titration process can require multiple visits to the
dentist over several months and the dentists lack feedback on compliance and efficacy during and after
titration. Inflammation of the temporomandibular joint (TMJ) resulting from the fixed and continuous artificial
advancement of the mandible can also occur. The proposed connected auto-titrating, SDB sensing, oral
appliance can mitigate issues with the titration process and be optimized to provide minimum therapy
necessary to improve user safety and comfort. RRR and collaborators propose to show feasibility of a
fully-in-the-mouth micro manipulating oral appliance by developing a prototype appliance and demonstrating
functionality in an overnight human study of people suffering from SDB. RRR has assembled a highly qualified
team of Sleep and Oral Medicine experts and experienced medical device designers to achieve these goals.

Public health relevance
Project Narrative Sleep Disordered Breathing is a serious medical issue associated with diminished quality of life, premature death, and significant financial burden. Continuous positive airway pressure (CPAP) is the gold standard therapy, however half of users prescribed CPAP stop using it over time. Oral appliances, mouthguard-like devices that hold the lower jaw forward during sleep to open airways, provide an alternative therapy to CPAP. This project seeks to develop a new, smart oral appliance that adjusts and optimizes its positioning automatically during the night. We anticipate that this intelligent automation will reduce several burdens and deficiencies associated with existing oral appliances including the difficult fitting process and the potential for jaw problems.